Glucose Variability as a Digital Biomarker for Preclinical AD Risk in Prediabetes.

PROJECT ABSTRACT
Reliable diagnostic digital tools are needed for the early detection of cognitive dysfunction and stratification of
early Alzheimer’s Dementia (AD) risk among older adults at risk for Type 2 diabetes (T2DM). T2DM is a well-
known accelerator of cognitive decline and AD risk: T2DM is linked to dysfunction in episodic memory and
executive functions, and proffers a 2- to 4-fold increased risk for AD. The prediabetes stage may be key to
understanding this accelerated aging as it could provide an optimal window into the initial pathophysiological
changes that trigger cognitive dysfunction and AD. However, uncertainty surrounds the role of hyperglycemia
in the prediabetic stage, perhaps because only assessing peaks in glucose sporadically using single time-point
measurements like hemoglobin A1c (HbA1c) and fasting glucose leaves key aspects of dysglycemia
unexamined. These limitations open the possibility that more precise measurement of dysglycemia will yield a
more definitive understanding of the mechanisms by which T2DM pathophysiology modifies cognitive function
and AD risk, which are presently unknown. We will be the first to leverage cutting-edge Continuous Glucose
Monitoring (CGM) technology to investigate the precise associations between dysglycemia, cognitive function,
and key AD biomarkers in older adults with at risk for T2DM. CGM allows for the precise assessment of
fluctuations in glucose levels to show individualized patterns of hyper- and hypoglycemia over days- a major
component of dysglycemia not reflected in fasting glucose or HbA1c. Because CGM technology has almost
exclusively been used by people with a T2DM diagnosis, examining those at risk for T2DM is innovative. Our
established multidisciplinary research team, with expertise in behavioral medicine, endocrinology, geriatrics,
neuropsychology, and neurology, and numerous years of collaborative clinical research experience, is well-
positioned to examine among 40 older adults at risk for T2DM (a) the association of glycemic fluctuations with
cognitive dysfunction in episodic memory and executive functions, key domains that show decrements both
early in the AD trajectory, and in prediabetes, and (b) explore, for the first time, the association of glycemic
fluctuations with well-established biomarkers of early AD risk. These plasma-based AD biomarkers of tau
phosphorylation and amyloid burden are cost-effective, require minimally invasive blood draws, and minute
amounts of brain-specific proteins in blood for use with ultrasensitive immunoassays. By leveraging precise,
scalable technology to assess early glycemic fluctuations, and sensitive screening tools for early AD risk, this
innovative proposal stands to make both scientific and technological advances in aging and AD risk research.
Support for our hypotheses would introduce cost-effective, user-friendly CGM technology as a novel, sensitive,
digital biomarker for the early detection of cognitive dysfunction and stratification of AD risk, ultimately, helping
older adults preserve cognitive function into later life.

Public health relevance
PROJECT NARRATIVE The impact of prediabetes on the future risk for cognitive dysfunction and Alzheimer’s Disease (AD) is of great public health significance considering that a) every 1 in 3 people in the US, including half of all adults aged 60 and older have prediabetes, and b) type 2 diabetes is a strong and consistent risk factor for AD. With the availability of accurate and reliable digital technology to detect individualized glycemic patterns and abnormalities much earlier than conventional glucose metrics, as well as cost-effective, sensitive plasma- based screening tools for early AD risk, we have an unparalleled opportunity to understand how T2DM pathophysiology accelerates cognitive decline and AD risk. The proposed research is relevant to NIA’s mission of accelerating discovery of digital biomarkers for the early detection of Alzheimer’s disease and related cognitive dysfunction.